Readiness for Change Scale: Adaptation and Validation for Mental Health Task-Sharing

Readiness for Change Scale: Adaptation and Validation for Mental Health Task-Sharing
PROJECT SUMMARY:
Mental health task-sharing, or the involvement of non-specialist health workers (NSHWs) such as community
health workers (CHWs) to make mental health care more available and accessible, has been proven to be
efficacious in randomized controlled trials in multiple low-resource settings including low- and middle-income
countries. However, in routine care settings, the impact of mental health programs based on task-sharing
paradigm greatly depend on its adoption by CHWs and the fidelity with which they implement it which, in-turn, is
influenced by their readiness for change (RFC). However, there is dearth of literature assessing the role of RFC
as an important predictor of CHW adoption and fidelity within mental health task-sharing. Importantly, research
on RFC among CHWs within mental health task-sharing is hindered by the absence of a culturally-adapted,
reliable, and valid measurement tool. To address this significant gap in research and knowledge, we build on
our previous qualitative work investigating the cultural- and context-specific nuances of RFC among Accredited
Social Health Activists (ASHAs), a cadre of female CHWs in India, for engaging in mental health task-sharing.
Utilizing our qualitative findings, we aim to adapt the Readiness for Change Scale and translate it into Marathi
language by following the World Health Organization's recommendations on scale translation. In addition, we
aim to assess the content and construct validity, as well as internal consistency of the translated (Marathi) version
of the Readiness for Change Scale among n=330 ASHAs in Rahata sub-district of Ahmednagar district in the
state of Maharashtra, India. We will assess content validity through involving an expert panel, and calculate
content validity ratios and a content validity index. For evaluating construct (convergent) validity, we will calculate
the correlation between the revised scale scores and scores from the General Self-Efficacy Scale. Furthermore,
we will use Cronbach's alpha to assess the internal consistency of the revised scale, and factor analysis to
identify scale constructs. The outcome of this study—an adapted and validated measure for RFC among CHWs
for mental health task-sharing—will build a solid foundation to develop and test an implementation strategy to
build RFC among CHWs for mental health task-sharing through NIH's R21 funding mechanism which will be
useful for low-resource setting globally, including the United States.

Public health relevance
PROJECT NARRATIVE: The proposed project aims to address the current absence of a culturally and contextually relevant, and validated tool to measure readiness for change (RFC) among non-specialist health workers (such as community health workers) for the adoption and successful implementation of mental health task-sharing. Such a measurement tool is relevant to public health because it could lead to systematic investigation of strategies to build RFC in this population and enhance their adoption of mental health task-sharing and the fidelity with which they deliver it. This will ultimately help alleviate the challenges brought upon by the dearth of mental health professionals globally, including low-resource settings in the United States, and thus, the proposed research is also relevant to the part of NIMH's strategic plan to build models to scale-up evidence-based practices for use in routine care settings.